Development of a long-lasting, bone-targeted gene therapy for osteogenesis imperfecta

PROJECT SUMMARY
Osteogenesis imperfecta (OI) is the most common bone fragility disease, with an incidence of approximately 1
in 25,000–50,000 individuals in the US. OI is an inherited genetic disorder caused by mutations in the genes
involved in collagen production, processing, and cross-linking. Genetic mutations and phenotypes in OI
patients are highly variable, so current treatments mainly focus on symptomatic improvements, such as
increase bone mass and strength to reduce bone fragility, fracture, and pain, using the drugs initially developed
to treat osteoporosis. One innovative approach to treat OI patients who require life-long treatments is a
long-lasting, bone-targeted gene therapy that improves skeletal health using recombinant adeno-
associated virus (rAAV). To avoid potential off-target adverse effects of AAV gene therapy in non-skeletal
tissues, we improved rAAV9 serotype’s bone-specific tropism and expression by implementing a novel bone-
targeted capsid and incorporating miRNA-mediated repression of transgene expression in the liver, muscle,
and heart into the vector design. Using this bone-tropic rAAV, we enhanced bone-forming WNT signaling in
osteoblasts (OBs) by silencing the expression of two WNT inhibitors, Sclerostin (Sost) and Schnurri3 (Shn3).
Here, we propose that with a single treatment, systemic delivery of the bone-tropic rAAV conferring single or
dual silencing of Shn3 and/or Sost improves bone mass and strength, and increases grip strength, promotes
the healing of fracture, and improves mobility in OI mice. We will determine the molecular mechanisms of how
these processes occur using mouse and human OI skeletal organoids.
First, we will examine whether bone-tropic AAV:WNT modulators improve skeletal health in OI mice
(Aim 1). Given that bone-tropic rAAV-mediated silencing of Shn3 and/or Sost promoted bone formation by
augmenting WNT/b-catenin signaling and OB function in osteoporosis, this aim will examine their ability to
ameliorate skeletal deformities and increase bone mass and strength throughout the skeleton, promote
fracture healing, and enhance grip strength and mobility in mice with three different subtypes of OI forms. OI
skeletal phenotypes continuously develop throughout lifetime, so we will examine rAAV’s effectiveness and
durability at multiple intervention timepoints. Next, we will determine molecular mechanisms of bone-tropic
AAV:WNT modulators using mouse (Aim 2) and human (Aim 3) OI skeletal organoids. The 3D-skeletal
organoids seeded with mouse or human OI-OBs will be developed for in vitro culture or implantation into a
xenograft mouse model. These organoids will allow us to study the molecular actions of the bone-tropic rAAV
reversing abnormalities in WNT/b-catenin signaling, osteoblast and osteocyte development, mineralization
activity, and collagen biochemistry. We will perform transcriptome profiling of AAV-transduced OI-OBs to
identify the downstream regulators of the WNT pathway contributing to collagen production and processing.
Successful completion of these aims will provide proof-of-concept evidence for bone-tropic AAV gene therapy
as an alternative long-lasting treatment option for OI patients and improve our understanding of its
mechanisms of action in the treatment of OI.

Public health relevance
PROJECT NARRATIVE Osteogenesis imperfecta (OI) is the most common bone fragility disease, with an incidence of approximately 1 in 25,000–50,000 individuals in US. OI is an inherited genetic disorder caused by mutations in the genes involved in collagen production, processing, and cross-linking. A long-lasting, bone-targeted gene therapy that promotes bone formation using a recombinant adeno-associated virus can improve therapies for OI patients who require life-long treatment, while limiting potential off-target adverse effects in non-skeletal tissues.